Creating a disease-agnostic scalable platform for decentralized observational and validation of digital biomarkers studies and piloting it for people with familial ALS and ultra-rare MNDs

PROJECT SUMMARY
One of the greatest challenges facing biomedical sciences is the development of fundamentally better treatments
for neurodegenerative diseases. Natural History studies (NHS) are critical to enhance our understanding of the
disease, find external matching controls, identify people living with rare and ultra-rare forms of the diseases, and
bring them into clinical research ecosystem.
The heterogeneity of ALS and other neurodegenerative diseases complicates predictions of disease progression
and development of potential therapies, making clinical trials challenging. Uncertainty surrounding prognosis is
an enormous burden for people with ALS and their families. Implementing better models to identify and recruit
people living with ultra-rare forms of diseases like ALS with known genetic mutations or PLS is essential.
“Traditional” models of NHS in ultra-rare diseases are not effective, as participating in NHS research sites are
being selected first, while people living with those conditions may not be attending the preselected clinics.
While the Food and Drug Administration encourages the use of approaches and technologies to minimize the
burden of trials on patients and limit the need for travel to study sites and is open to exploring the utility of digital
biomarkers as clinical endpoints, implementation of such methods as decentralized clinical research with key
endpoint measures at baseline and at intervals during the trial conducted in a standardized fashion at central
testing facilities, remote monitoring for some of the visits, etc. are not utilized broadly..
We propose a decentralized model for the NHS conduct, in which we implement a disease-agnostic people-
centric Platform, NeuroPRO™, for recruitment and e-consent study participants, diagnosis confirmation, and
baseline data acquisition. This Platform will be used to:
• Conduct a stand-alone decentralized longitudinal NHS utilizing digital biomarkers and periodic home or
nearest clinical hubs visits.
• Conduct a hybrid NHS, in which this people-centric platform may serve either as an equal partner to a
“traditional” NHS (ALS/MND Natural History Study), or as participants identification and recruitment tool,
while clinical outcomes are still being measured during clinical visits, or as also an optimization tool for
participating sites selection based on geographical distribution of recruited participants (PLS Natural
History Study).
• Provide regulatory compliant environment for rapid simultaneous validation of digital biomarkers against
widely utilized outcomes.
The data from the studies will be anonymized and shared with the medical research community.

Public health relevance
PROJECT NARRATIVE As neurodegenerative diseases have substantial heterogeneity in clinical presentation and no effective cures, Natural history studies (NHS) are essential to enhance our understanding of the disease, find external matching controls, identify people living with rare and ultra-rare forms of the diseases, and bring them into clinical research. Current “traditional” models of NHS in ultra-rare diseases try to search for people living with those conditions “under the lamppost” of the participating clinics, while a decentralized model with utilization of a disease-agnostic people-centric platform, NeuroPRO™, with digital biomarkers’ capture and periodic home or nearest clinical hubs visits will be more efficient in ultra-rare diseases like PLS or familial ALS. We propose to pilot NeuroPRO in three diverse settings that will cover majority of decentralized research models: • A stand-alone patient-centric longitudinal NHS utilizing digital biomarkers and, if required, periodic home or nearest clinical hubs visits, • A hybrid NHS, in which patient-facing NeuroPRO and a “traditional” site-based NHS recruit participants and capture data as equal partners, and • NeuroPRO serving as a regulatory compliant environment for rapid simultaneous validation of digital biomarkers against “standard” disease-specific biomarkers and outcomes.